Role of the Immune Response in Spiral Ganglion Neuron Death After Hair Cell Loss

Project Summary
Sensorineural hearing loss, the most common form of hearing loss, is characterized by damage to inner
ear sensory hair cells or to the spiral ganglion neurons (SGNs) that conduct auditory information from the hair
cells to the brain. SGN death can occur because of direct trauma, e.g., acoustic overexposure, or secondarily
after hair cell loss. Degeneration of SGNs can reduce the efficacy of cochlear implants that replace the function
of hair cells by electrically stimulating SGNs. The mechanisms that promote SGN death after hair cell loss are
unknown, however, mounting evidence suggests a causal role of the immune response.
Neonatal rats treated with the ototoxic aminoglycoside antibiotic kanamycin lose all hair cells by 3 weeks of
age, rendering them deaf, and subsequently lose more than 80% of SGNs by 17 weeks of age. Gene
expression profiling analyses from the Green lab indicate that post-deafening, there is a significant increase in
the expression of immune response related genes in the spiral ganglion. This is accompanied by a significant
increase in macrophage number and activation up to two weeks prior to the start of significant post-deafening
SGN death. In addition, lymphocytes (CD4+ helper T cells, CD8+ cytotoxic T cells, and CD161+ NK cells)
increase in number within the spiral ganglion concurrent with the first indication of significant post-deafening
SGN death. This increase in immune cell abundance and activation persists throughout the neurodegeneration
period, indicating a robust and prolonged immune responses occurs in the cochlea after kanamycin-induced
hair cell loss. I hypothesize that this immune response is causal to SGN death after hair cell loss.
In this proposal, I will elucidate the function of macrophages and lymphocytes, independently, to determine
their involvement in SGN degeneration after hair cell loss. First, I will test the hypothesis that macrophages are
required for SGN after hair cell loss by evaluating three primary criteria. Using immunohistochemistry, I will
assess 1) SGN survival and 2) recruitment of lymphocytes (CD45+/IBA1- cells) in deafened PLX5622-fed
macrophage depleted rats. These experiments will indicate the extent to which macrophages are required for
SGN death and lymphocyte recruitment, respectively. In addition, I will use 3) qPCR to measure gene
expression of key chemokines/cytokines in the spiral ganglion to determine the extent to which macrophages
may be creating an environment neurotoxic to SGNs. Secondly, I will test the hypothesis that lymphocytes are
causal to SGN death after hair cell loss using the T, B, and NK cell deficient SRG rat strain. Together, the
results of these experiments will determine the extent to which macrophages and/or lymphocytes contribute to
SGN death after hair cell loss. These results will help guide the development of future therapeutics aimed at
preventing SGN degeneration after hair cell loss, ultimately improving the efficacy of cochlear implants.

Public health relevance
Project Narrative Spiral ganglion neurons (SGNs) of the auditory system slowly die after loss of auditory receptors called inner ear hair cells. Loss of either SGNs or inner ear hair cells negatively impacts normal hearing and efficacy of cochlear implants. This proposal will elucidate the neuroimmune interactions that promote SGN degeneration after inner ear hair cell loss, providing a foundation for the development of therapeutics aimed at maintaining SGN survival, ultimately improving normal hearing and efficacy of cochlear implants.